Characterizing Wnt Signaling Pathways in Axon Guidance

DESCRIPTION (provided by applicant): Although many axon guidance molecules have been identified, the signaling and cell biological mechanisms leading to directed axon growth are still poorly understood. Building on our progress, we will ask in-depth questions about novel signaling and cell biological mechanisms of axon guidance. Specifically, we will use Frizzled3 phosphorylation and trafficking as a tool to solve how signaling asymmetry is generated in the growth cone and the cell biological mechanisms involved in turning. We will also use genetic mosaic approaches to study axon-axon interactions to address the unanswered question of how a group of axons pathfind together.

Public health relevance
PUBLIC HEALTH RELEVANCE: This study proposes to discover novel signaling and cell biological mechanisms of axon guidance in development of functional circuits. These studies will provide basic scientific basis for therapeutic designs for neural circuit repair.